Mechanism of non-oncogene addiction

Abstract
With the advent of personalized cancer medicine, mutations in tumors can be paired with targeted therapies
such as tyrosine kinase inhibitors (TKI). However, even the most potent TKI fail to eradicate all cancer cells.
Subsequently, tumor-repopulating cells within minimal residual disease (MRD) contribute to patient relapse.
The application of Abl-kinase inhibitors to the BCR/ABL oncoprotein in chronic myelogenous leukemia (CML) is
a paradigm for personalized medicine. TKI therapy in CML leads to long lasting therapeutic benefit; however,
MRD remains and can eventually evolve to blast crisis. Although the molecular mechanisms underlying the
failure of TKI to eradicate CML MRD are not known, growth factor signals are suspected to replace the TKI-
disabled oncoprotein survival signals. We have determined that c-Fos and Dusp1 are critical for growth-factor-
mediated TKI resistance. Both genetic and chemical inhibition of Dusp1 and c-Fos render CML exquisitely
sensitive to TKI, and cure a mouse model of CML. Overall, our published and preliminary data suggests that
expression levels of c-Fos and Dusp1 determine the threshold of TKI efficacy during chronic CML disease.
Extending this line of investigation, the proposed research will determine whether c-Fos and Dusp1 are
necessary and sufficient for the evolution of CML to blast crisis, and whether c-Fos and Dusp1 levels
determine response to TKI in blast crisis. Next, we hypothesize that Fos and Dusp1 signals converge upon
oncogenically-activated enhancers. We propose that Fos-Jun AP-1 complexes facilitate oncogenically active
enhancers, while in the absence of c-Fos and Dusp1 signals, Jun-JunD AP-1 complexes predominate but do
not support tumor maintenance. Specifically, we will molecularly link c-Fos-Jun AP-1 and Dusp1 activity to
global enhancer chromatin dynamics. Moreover, we will exploit chromatin-embedded target-gene-reporter
alleles to provide a detailed analysis of functionally-relevant downstream genes at a single-cell level in primary
CML cells. The proposed work is expected to delineate the necessity of c-Fos and Dusp1 in CML-blast-crisis
TKI sensitivity, as well as to provide deep molecular insight into the mechanisms underlying blast crisis and
cytokine-mediated TKI resistance. We expect that this information will be informative not only for CML and
blast crisis, but also the broad group of tyrosine-kinase oncoprotein-driven tumors that are not cured by TKI.

Public health relevance
Tyrosine kinase inhibitor (TKI) therapy has been developed for chronic myelogenous leukemia (CML) and several solid tumors, including breast, prostate and lung cancers.! However, even the most potent kinase inhibitors are not curative for CML, and result in minimal residual disease (MRD) which eventually leads to blast crisis. MRD cells have been shown to survive TKI therapy by paracrine growth factor signaling, which maintain cell quiescence and mediate survival signaling regulatory networks. This grant application will exploit well- established CML models to investigate the molecular and cellular basis exploited by tumors to survive TKI therapy. We expect that this information will be informative for the broad group of tyrosine-kinase oncoprotein- driven tumors that are not cured by TKI.